Development of Human Dorsal Visual Cortex

PROJECT SUMMARY
The dorsal visual stream is one of the two major processing pathways in human visual cortex, and is involved
in attentional and spatial aspects of vision critical for attending to, filtering, and interacting with the visual
environment. The retinotopic maps which comprise the dorsal visual stream have never been mapped across
development. This is a fundamental gap in the neuroscience of vision, with no existing models for how the
structural and functional development of a major visual processing pathway drives behavioral maturation.
Leveraging our prior working in population receptive field (pRF) mapping of ventral visual stream development,
we propose a rigorous multimodal approach combining functional magnetic resonance imaging (fMRI),
quantitative MRI (qMRI), neuroanatomical mapping, and the innovative use of bespoke video game-based
experiments to engage children to measure the dorsal visual stream in childhood, adolescents, and adults.
Collecting multiple forms of data on each individual allows us measure how simultaneous changes in function
and fine-scale tissue structures in the living brain are coordinated to impact behavioral development. The work
is structured around three aims. Aim 1 will produce two developmental atlases of the dorsal visual
stream: a functional atlas defining how dorsal stream maps of visual space are organized, and a
structural atlas charting fine-scale tissue development in the same maps unfolds across neurotypical
development. Using fMRI, qMRI, and behavioral measures, we quantify how the growth or loss of visual
space representations across development in parietal cortex is related to changes in tissue structures such as
myelin and neuropil density, and how each of these relate to the development of visuospatial attention. Aim 2
will determine how broader functional tuning of the dorsal visual stream matures. Using fMRI and
behavioral metrics, we will perform pRF modeling to quantify how representations of space, motion, and
numerosity differ between children and adults. Aim 3 will quantify how the visual ability to dynamically
shift the locus of spatial attention is constrained by functional development of the dorsal stream. Using
fMRI and a novel game-based experiment, we overcome hurdles to engage children in a task in which spatial
attention is paramterically altered to determine how dynamic properties of receptive fields—their ability to
change size and position—mature into adulthood and constrain ecological visual behaviors such as reading
ability. Overall, these data will establish a normative trajectory of the dorsal visual stream's development, both
structurally and functionally, filling longstanding gaps in visual neuroscience. A structural-functional atlas of
visual cortex will equip researchers with a neurotypical model to better characterize visual disorders that likely
result from atypical development of the dorsal visual stream, such as cortical visual impairment (CVI).

Public health relevance
PROJECT NARRATIVE The dorsal aspect of human visual cortex underlies behaviors critical to everyday life, including our ability to attend to, and interact with, stimuli in our visual environment as is done during reading or visual search. The lack of developmental work charting how dorsal visual cortex emerges during childhood is a significant gap in pediatric health, given that disruptions in these visual abilities are reported in developmental disorders such as cortical visual impairment (CVI) , attention-deficit/hyperactivity disorder (ADHD), and dyslexia. Here, the production of atlases detailing the functional and structural development of dorsal visual cortex will provide fundamental knowledge of the developing visual system, which will in turn provide a neurotypical model necessary for breaking ground in disorders such as CVI and dyslexia.